Biological and Physiological Mechanisms of Symptom Clusters in Heart Failure (BIOMES-HF)

PROJECT SUMMARY
Symptom burden continues to be a significant problem for millions of adults living with heart failure (HF), the
fastest growing cardiovascular condition in the U.S. Symptoms, which often co-occur or cluster together, are of
utmost importance in HF because they predict quality of life and clinical events. There is considerable
heterogeneity in symptoms in HF, however, that is particularly evident in the vulnerable transition period after a
hospitalization for acute decompensated HF. While symptoms improve for some patients and they have longer
periods of relative stability, others are plagued by enduring symptoms leading to poor outcomes, including
rehospitalization. Given little-to-no association between hemodynamic markers (e.g. ejection fraction) and
symptoms in HF, our clinical efforts to optimize hemodynamic stability during a hospitalization may not
translate to improvement in symptoms post-hospitalization. Many studies have shown that HF is not just a
hemodynamic, “pump failure” problem, but that it is a multifactorial, systemic condition involving processes
such as inflammation, sympathetic dysregulation, and endothelial dysfunction. Based on research by our group
and others, we propose that a multi-biomarker panel and the physical frailty phenotype that capture the
multifaceted nature of HF might tell us more about symptoms in HF than our current objective markers.
Therefore, the purpose of the proposed research is to 1) identify clusters of change in symptoms after a HF
hospitalization and 2) quantify longitudinal associations between symptoms, biomarkers, and physical frailty.
We will address the following aims through a gender- and age-balanced longitudinal study of 240 adults during
the 6 month transition period after a hospitalization for acute decompensated HF: 1) identify clusters of change
in physical symptoms among adults with heart failure, 2) quantify longitudinal associations between biomarkers
and physical symptoms among adults with heart failure, and 3) quantify longitudinal associations between
physical frailty and physical symptoms among adults with heart failure. We will use advanced quantitative
modeling, including growth mixture modeling and longitudinal mediation modeling, to examine changes in
symptoms, biomarkers, and physical frailty post-HF hospitalization and associations therein. This innovative
study will advance HF symptom science by utilizing a multi-biomarker panel and the physical frailty phenotype
that capture the multifaceted nature of HF, coupled with advanced quantitative modeling, to characterize
heterogeneity and identify potential mechanisms of symptoms in HF. As a result, this research will inform the
next phase of this program of research by pinpointing amenable targets for intervention to provide better,
individualized treatment to improve symptom burden in HF.

Public health relevance
PROJECT NARRATIVE Heart failure, the fastest growing cardiovascular condition in the United States, is associated with significant symptom burden. The results of this study will shed light on our understanding of the role of biological and physiological mechanisms in explaining heart failure symptoms, particularly groups of co-occurring symptoms, over time. The knowledge generated from this study will be used to develop personalized symptom management interventions for adults with heart failure.